Electrochemical Therapy for Scar Treatments (Resubmission)

Project Summary
Hypertrophic scarring (HTS) leads to severe disfigurement and loss of function in deep partial thickness
burn injuries with occurrence following burn injuries ranging from 33 to 91%. HTS can occur with any
cutaneous injury and is associated with injuries that take longer than 2-3 weeks to heal and is
characterized by thickened, wide, and raised scars due to abnormally excessive collagen growth. If scars
are located near joints, they could lead to decreased mobility due to skin contractures. To address this
need, we are developing a low-cost electrochemical therapy for skin based on redox chemistry. By
producing acid/base within tissue with microneedle-electrodes, the ECT may soften the thickened
collagen tissues and low-grade cellular death to trigger the regeneration of normal rather than aberrant
collagen structure. If ECT is effective, its practical advantages are low-cost, simple use, and point of care
delivery with relatively low risks. We hypothesize that the ECT can create ‘controlled’ injuries that remodel
damaged tissue/collagen and thus replace hypertrophic scars. The goal of our proposed work is to
establish the feasibility of ECT as a scar reduction tool. First, we will fabricate and optimize a custom
ECT control unit with capability of potential driven electrochemistry. Second, we will identify safe and
efficient dosimetry with ex vivo porcine specimens. Last, we will apply the safety dose range ECT to in
vivo hypertrophic scar model.

Public health relevance
Public Health Relevance Hypertrophic scarring (HTS) leads to severe disfigurement and loss of function in deep partial thickness burn injuries with occurrence following burn injuries ranging from 33 to 91%. Unfortunately, for many with visible hypertrophic scars but with no functional impairments, their treatments are not covered by insurance and their out-of-pocket cost can easily reach above $3500. To address this need, Incipian is developing an easy-to-use, affordable, and less traumatic scar treatments that could expand accessibility.